Project 1: InHANCE: Novel Biomedical Imaging Approaches to Address Radiation-Induced Toxicity for Head and Neck Cancer Patients

ABSTRACT: Project 1
Current standard-of-care external beam radiotherapy (EBRT) for head and neck cancer (HNC) is associated with
high rates of severe toxicities affecting patients’ quality of life. Given the excellent outcomes for human
papillomavirus (HPV)-associated HNC and long-term survival of these typically younger patients, normal tissue
sparing, and prevention of long-term toxicities aimed at improving survivorship, while maintaining excellent
disease control, represents a major healthcare challenge.
The aims of this proposal are focused on the overarching hypothesis of this application that the use of novel
biomedical dose-imaging approaches will facilitate the prevention, monitoring, and treatment of RT-
induced osteoradionecrosis (ORN) for HNC patients. Our group has recently identified mandibular dose-
volume parameters associated with higher likelihood of ORN development. The first project of this proposal aims
to prevent post-EBRT bone toxicity by using the identified mandibular dose-volume parameters as IMRT plan
constraints. We will also develop and validate high-dimensional risk assessment models that may be more
accurate for ORN risk stratification. The second project aims to use a novel combination of MRI sequences to
quantitatively assess mandibular cortical bone microstructural integrity. Novel and validated MRI sequences will
be used to assess the effects of pharmacologic therapy on vascular integrity of the mandible. The final project
aims to reduce surgical morbidity for patients who have already developed ORN by functional image-guided pre-
surgical bone injury mapping for surgical planning to optimize the resection volume and achieve better surgical
outcomes.
The successful implementation of the study aims will directly leverage the efforts from a previously funded NIDCR
award (R01DE025248) and complement ongoing validation studies (U01DE032168) for the incorporation of MRI
assessment into routine clinical practice for improved prevention, early detection, and treatment of a devastating
radiation-induced morbidity such as ORN for HNC survivors. The study will also develop improved risk
assessment models and a novel MRI sequence combinations to assess mandibular bone integrity. Finally, the
study will demonstrate the potential of controlling surgical morbidity for patients with established toxicity through
better surgical planning using innovative functional imaging guidance.

Public health relevance
PROJECT NARRATIVE: Project 1 Despite the excellent treatment outcomes for human papillomavirus-associated head and neck cancer patients, their long-term survival is associated with a significant risk of major normal tissue toxicities related to radiotherapy. Improved survivorship through normal tissue sparing and prevention of long-term toxicity, while maintaining excellent disease control represents a major healthcare challenge. This project is focused on better prevention, early detection, and treatment of osteoradionecrosis, a devastating radiation-induced side effects for head and neck cancer survivors.